Parent Self-Regulation, Parent-Child Coregulation, and Harsh Discipline

PROJECT SUMMARY
The objective of this project is to improve scientific understanding of the etiology of harsh discipline in
terms of the role individual parent and dyadic parent-child regulatory processes play in harsh discipline use.
Harsh discipline, defined as the parent’s use of coercive and verbally aggressive commands and physical
punishment (e.g., grabbing, shaking, spanking) to discipline children, is widely condemned by researchers and
practitioners for its detrimental effects on children and yet still widely practiced by parents. This suggests that
either scientists lack information about what mechanisms underlie the recurrent use of harsh discipline and/or
that programs to prevent harsh discipline are insufficient. To more successfully reduce harsh discipline through
intervention, we need to identify intervention targets that are mechanistic in maintaining harsh discipline use
over time and are malleable in intervention. A prime candidate is regulatory processes in the parent and
parent-child dyad, which have been shown to underlie harsh discipline use and act as markers of improvement
in family intervention. Harsh parents show maladaptive emotional and biological reactivity and lower executive
function than controls, and parent-child dyads characterized by harsh discipline show more affective rigidity,
poorer behavioral contingencies (e.g., coercion), and weaker biological synchrony.
Parent self-regulation and parent-child coregulation involve interrelated affective, behavioral, cognitive, and
biological processes that unfold in real time. For their ecologically valid assessment, measures of dynamic,
time-sensitive regulatory responses in context are needed. But due to the complexity of modeling regulatory
processes and the system-level dynamics of interdependent dyads, most studies assess individuals, static
indicators, and single dimensions of regulatory processes. The present proposal will conduct an integrated
assessment of multiple regulatory domains to answer the question of how individual and dyadic regulatory
processes interact to support harsh discipline use over time. The dynamic analytic approaches proposed to
model regulatory processes have been shown to explain variance in risk above and beyond static indicators of
regulatory skills. Mixture structural equation models of emotional, behavioral, cognitive, and biological
regulatory processes at the individual and dyadic levels will be used to test relations among major constructs.
Programs previously shown to reduce HD often target the parent or the child but not dyadic processes.
Very few directly address parent self-regulation, and when they do, may only address one domain (e.g.,
emotion regulation). Cumulative contextual risk for HD (e.g., history of trauma, poverty, low parenting
resources) is intergenerationally stable and thus difficult to change. Thus, to illustrate the measurable potential
of parent and parent-child regulatory processes as malleable intervention targets, the proposed research will
also examine whether they explain variance in HD above and beyond cumulative contextual risk for HD.

Public health relevance
PROJECT NARRATIVE Harsh discipline is a detrimental parenting practice with a host of well-established negative developmental outcomes for children, yet it is still widely practiced by parents. To successfully reduce parental harsh discipline through intervention, we are in need of malleable targets that are both mechanistic in supporting harsh discipline use and are malleable in family intervention. The proposed research is designed to provide a stronger scientific understanding of the etiology of harsh discipline and the particular role of individual parent and dyadic parent-child regulatory processes as potentially malleable mechanisms that underlie and maintain harsh discipline use.